Outreach Core

Outreach Core Project Summary
The Outreach Unit of the Arizona Cancer and Evolution (ACE) Center will bring together students, researchers,
and the general public to consider the evolutionary pathways and ecology of cancer. We have three aims
within our Outreach Unit: (1) to integrate and synergize our interdisciplinary team to produce real innovation
and ultimately impact the field of cancer research; (2) to connect the Center with the wider Cancer Systems
Biology Consortium, other scientists and the public to promote collaboration; (3) to educate the next generation
of scientists and communicators in cancer research methods and encourage them to work in integrative teams
in order to stimulate new ideas. We will achieve these aims through a comprehensive program that includes
educational courses, online tutorial videos with accompanying monitored discussion boards, seminars,
internships and public lectures and also an innovative creative activity - a unique, immersive new media
exhibit, based on the work of ACE Center researchers, that visualizes the fundamental forces of evolution:
mutation, selection and drift in relation to the ecology of cancer cells. This project will explore the intersection
of science, art and technology to promote new ways of imagining scientific concepts. It will be displayed in
major public galleries and conferences.
IMPACT: We will stimulate public interest in cancer theory research and educate students, scientists and the
public about ACE advances and our drive to understand the nature of cancer and its evolutionary origins. We
will foster research and academic excellence and advance the goals of the National Cancer Institute.